Targeting the HIV-1 reservoir at cART initiation with CD4-mimetic interventions

Summary
Combination antiretroviral therapy (cART) fails to eliminate HIV-1 persisting in reservoirs or prevent long-term
complications in people living with HIV (PLWH); therapy interruption leads to rapid viral rebound. Therefore, new
approaches aimed at eradicating HIV-1 or enabling durable virus control without cART are needed. This is an
R01 application in response to the NOFO PAR-23-297: “Opportunities for HIV Cure Strategies at the Time of
ART Initiation (R01 Clinical Trial Not Allowed)”. This application is built on collaborative research centered around
the development and translation of small-molecule CD4-mimetic compounds (CD4mcs) as a cure strategy for
HIV-1. CD4mcs synergize with CD4-induced (CD4i) Env antibodies (Abs) to render virus-infected cells highly
vulnerable to antibody-mediated cellular cytotoxicity (ADCC) and clearance by immune effector cells. These
CD4i Abs are present in most PLWH. This application leverages the recent discovery of a new class of indoline
CD4mcs that displays remarkable improvements in antiviral potency and breadth against diverse primary HIV-1
strains. Treatment of HIV-1-infected humanized mice (hu-mice) with an indoline CD4mc and two types of CD4i
Abs (anti-CoRBS/anti-Cluster A Abs) at the time of cART initiation resulted in a dramatic reduction in the size of
the viral reservoir. This early CD4mc/Ab regimen enabled sustained virus control after analytical treatment
interruption (ATI)! Furthermore, we identified a new family of Abs in PLWH that recognizes additional CD4i Env
epitopes and that cooperate with indoline CD4mcs to significantly enhance ADCC.
In line with these exciting discoveries, this application proposes three independent and interactive aims:
Specific Aim 1 will investigate physiological variables (virologic parameters and timing of treatment) that facilitate
effective reservoir elimination by CD4mc/Ab interventions in new-generation hu-mice that support immune
effector cell function. In addition, multi-dimensional single-cell analytical techniques will identify the phenotypes,
physiology and spatial organization of immune-effector cells and virus-infected cells in tissues harboring HIV-1
reservoirs. These studies will determine the factors related to CD4mc/Ab intervention that tip the balance in favor
of durable viral control after ATI.
Specific Aim 2 will formulate a highly effective CD4mc/Ab cocktail by screening plasma of PLWH to identify
additional families of CD4iAbs with enhanced potency in mediating ADCC and evaluate them in hu-mice.
Specific Aim 3 will systematically explore how the properties of the infecting viral Env influence reservoir
establishment and susceptibility to elimination by the new indoline CD4mc/Ab cocktails in hu-mice.
The outcome of these proof-of-principle studies is expected to inform the development of a CD4mc/Ab-based
early intervention cure strategy for HIV-1.

Public health relevance
Project Narrative This project will use a potent small-molecule compound that mimics human CD4 to synergize with antibodies present in the plasma of people living with HIV (PLWH) to render virus-infected cells susceptible to killing by immune cells. The significance of this early intervention approach stems from its ability to drastically reduce the HIV-1 reservoir to an extent that HIV-1 infection can potentially be controlled by the body’s own immune system in the absence of life-long combination antiretroviral therapy.